Peripheral and central mechanisms of endometriosis pain

Abstract
Endometriosis is a prevalent chronic painful condition in which an endometrial-like tissue lesion grows outside
the uterus. The individual variability in endometriosis pain is large, and the factors contributing to it are unclear,
but central and peripheral mechanisms have been proposed. Thus, this study aims to identify the mechanisms
underlying endometriosis pain and the changes in pain after lesion removal surgery. We focus on central
mechanisms of inhibitory pain modulation capabilities and systemic estrogen levels, as well as peripheral
mechanisms involving estrogen receptor expression and local estrogen levels in the endometriosis lesion. We
hypothesize that higher local and systemic estrogen levels and estrogen receptor expression in the lesion, and
lower conditioned pain modulation (CPM) response will be related to greater endometriosis pain. In addition,
we hypothesize that after the surgery, patients with higher estrogen receptor expression and higher local
estrogen levels in the lesion (peripheral alterations) will have a greater reduction in endometriosis pain, while
patients with lower CPM response and higher systemic estrogen levels (central alterations) will have a lower
pain reduction. During the study, women with pelvic pain with and without endometriosis scheduled for an
operative laparoscopic surgery for endometriosis diagnosis and/or treatment will complete a baseline study
visit that includes a comprehensive characterization of their pain and endometriosis symptoms and
psychophysical assessments of the CPM response. During the surgery, a blood sample for systemic estrogen
level, a biopsy of the endometriosis lesion (if found), and a biopsy of healthy peritoneum will be collected and
analyzed for local estrogen levels and estrogen receptor expression using quantitative PCR (qPCR), enzyme-
linked immunoassay (ELISA) and western blot. After the surgery, patients will complete weekly surveys about
their pain and symptoms for 3 months. Regression models will be used to identify the factors related to
endometriosis pain and the change in pain after the surgery. A better understanding of endometriosis pain
could improve the treatment of endometriosis pain. Future studies will identify new or repurpose existing pain
treatments for endometriosis pain and develop a model that predicts which patients will have a significant pain
reduction after the endometriosis removal surgery for a personalized medicine approach.

Public health relevance
Project Narrative Endometriosis is a prevalent chronic painful condition however, the factors underlying and contributing to endometriosis pain are not clear. The goal of this study is to identify the central and peripheral mechanisms underlying endometriosis pain and the changes in pain after lesion removal surgery. The results of this study will address an important knowledge gap concerning endometriosis pain and will enable the identification of new interventions for endometriosis pain as well as predict which patients will have a significant pain reduction after the endometriosis removal surgery for a personalized medicine approach.